SouthEast Enrollment Center (SEEC)

A number of developments over the last decade are promoting bold new projects that can enable the promise
of precision or personalized medicine. While DNA sequencing costs continue to drop rapidly, equally important has been
the widespread adoption of electronic health records (EHR) allowing for the low cost, highly secure exchange of large
amounts of longitudinal health data from individuals. In addition, the increasing consumer adoption of mobile and personal
technologies offers the opportunity to link genomic and health data with exposure, behavioral, and other environmental
health data on a scale not previously possible. We must ensure that the benefits of these advances are accessible
to all. Key to the success of the All of Us Research Program (AoURP) will be the proportional inclusion of diverse groups.
This is a major strength of the “SouthEast Enrollment Center” (SEEC) consortium. SEEC will recruit 93,000 full participants
from Florida and Georgia into AoURP, including approximately 30% Hispanic/Latino and 30% Black/African American
volunteers. Importantly, half of the Hispanics will come from the Caribbean (e.g. Cuba, Puerto Rico and the Dominican
Republic) and the other half from South and Central America. Our sample of Blacks will include participants from Haiti and
English-speaking Caribbean islands. The Consortium will be spearheaded by four leading academic health centers in
Florida and Georgia. Each member brings a considerable track record of establishing genomic cohorts, recruiting
minorities into clinical research, forming community engagement partnerships, and sharing medical records across large
networks (e.g. all participate in PCORnet).

Public health relevance
No Text